Research Training in Pediatric Critical Care Medicine

ABSTRACT
The need for increased academic physician-scientists in Pediatric Critical Care Medicine, and collaborative
rigorous investigation of new treatment modalities with focus on pathobiology, health disparities, and long-term
morbidities, is clear. This renewal application requests the resources to continue our four-year post-doctoral
research training program in Pediatric Critical Care Medicine within the Department of Pediatrics at the University
of California, San Francisco. The goal of the program, which began in 2006, is to increase the number of highly
trained, successfully funded and sustainable pediatric critical care physician-scientists, who will perform high
level laboratory, clinical-translational, and/or health services research that will ultimately improve our
understanding of the pathobiology of critical illness, improve short and long-term outcomes, and reduce the
incidence of children with residual disabilities and/or chronic disease. To this end, this program aims to provide
comprehensive science training and mentoring career development for pediatricians with an M.D. or M.D./Ph.D.
degree who commit themselves to an academic career with a strong research component. The key elements of
the training program are (1) a mentored research experience, (2) scientific course work, (3) career development
workshops, (4) interdisciplinary experiences, (5) continuing review and evaluation. The centerpiece of the
program is the continuation of a 4-year fellowship training program, with two years devoted to intense research
training in basic laboratory, clinical-translational, health services, or epidemiologic science related to pediatric
critical care disease. A large number of exceptionally qualified faculty have committed their support as mentors
for fellows supported by the proposed training grant. These faculty are affiliated with several of the UCSF
campuses and organized research units and programs (i.e., the Cardiovascular Research Institute and the
Department of Epidemiology and Biostatistics), and several UCSF clinical campuses including UCSF Benioff
Children’s Hospitals in SF and Oakland, and the Zuckerberg SF General Hospital and Trauma Center. All fellows
will take courses in (1) Responsible conduct in research; (2) Scientific writing; (3) Art of lecturing; (4) Statistical
Analysis; and (5) Bioinformatics. In addition, all trainees and faculty will complete DEI training. A strong Trainees
Mentoring Program will support post-doctoral fellows in their training and career development. Mentors will meet
with the fellow on a regular basis, to assist him/her in setting and monitoring training and career goals. The
program has a strong track record in recruiting and training pediatric sub-specialists. Amongst the 16 trainees
who have completed training, 15 career development awards have been received. In addition, our first two
trainees have received RO1 funding, and 15 of the 16 continue in full-time academic faculty appointments. Thus,
the rationale for this renewal is based on the well-documented need for well-designed training programs to
prepare pediatric-scientists for a sustained productive career in Pediatric Critical Care research and the fact that
UCSF has the vision, experience and infrastructure to train the next generation of leaders in pediatric science.

Public health relevance
PROJECT NARRATIVE The need for increased academic physician-scientists in Pediatric Critical Care Medicine, and collaborative rigorous investigation of new treatment modalities with focus on pathobiology, health disparities, and long-term morbidities is clear. The goal of the training program is to increase the number of highly trained, successfully funded and sustainable pediatric critical care physician-scientists, who will perform high level laboratory, clinical- translational, and/or health services research that will ultimately improve our understanding of the pathobiology of critical illness, improve short and long-term outcomes, and reduce the incidence of children with residual disabilities and/or chronic disease.